ISOLATION AND USES OF CGMP PHOSPHODIESTERASE CDNAS

The cyclic nucleotide phosphodiesterases are crucial components in the regulation of the signal transduction cascades mediated by cAMP and cGMP. The size of this family of enzymes and the complexity of their regulation may not be adequately appreciated. The importance of studying them stems from their intrinsic biochemical and biological interest and from the fact that they are the targets of anti-asthmatic, anti-thrombolytic, cardiotonic, and anti-depressant drugs. Although they have been studied at the biochemical level for many years, the cDNAs and genes of some isoforms have been difficult to clone and this has now become a necessity. We have developed a genetic selection procedure that allows recovery of cDNAs coding for these enzymes. Conditions have been created in which lambda lysogens of E. coli that are capable of expressing a functional cyclic nucleotide or cGMP phosphodiesterase can grow. This method has been used to recover cDNAs that may code for a cGMP stimulated cGMP specific phosphodiesterase from Dictyostelium discoideum. The cGMP mediated signal transduction cascade and this phosphodiesterase regulate the motility of this organism and will be used to ask questions about how cGMP mediated signal transduction controls mobilization of the cytoskeleton and other developmentally important events. The same selection procedure will be improved and extended to recover selected mammalian phosphodiesterase cDNAs and to study their molecular, biochemical, and pharmacological properties.